Long-Term Adherence to Monitoring/Treatment in Underserved Asian Americans with Chronic HBV

PROJECT SUMMARY
Full Research Project 1 – Liver Cancer
Long-Term Adherence to Monitoring/Treatment in Underserved Asian Americans with Chronic HBV
TU FCCC: Grace X. Ma, PhD (Co-Leader) and Nestor Esnaola, MD, MPH (Co-Leader, URM ESI)
HC: Sarit A. Golub, PhD (Co-Leader) and Chibuzo Enemchukwu, MD (Co-Leader, URM ESI)
Although Asian Americans make up 6% of total U.S. population, they account for over 50% of Americans with
chronic hepatitis B (CHB), which is associated with 75% of hepatocellular carcinoma (HCC), the most common
type of liver cancer. Asian Americans as a liver cancer disparity population are 8-13 times more likely to
develop liver cancer with 60% higher death rate than non-Hispanic whites (NHWs). Research indicates that
blood tests every six months and an abdominal ultrasound every 12 months, combined with antiviral treatment
(e.g. entecavir or tenofovir) when appropriate, is the gold standard of care to reduce the risk of liver disease
(including HCC). However, adherence to monitoring and antiviral treatment guidelines among Asian American
patients with CHB is as low as 40% to 53%. Poor healthcare access and significant cultural barriers may
prevent long-term adherence to monitoring and optimal treatment, placing Asian Americans at a
disproportionately high risk for HCC and increased healthcare costs. Building on previous studies on a patient
navigator-led intervention to improve monitoring and care among noncompliant Asian American with CHB,
conducted by our established academic-clinical-community research team, we developed and pilot tested a
virtual patient navigation toolkit system (VPN toolkit) to replace our traditional patient navigator-led CHB
management. Since our preliminary data and other studies indicate that text messaging (TM) interventions
have potential to significantly improve adherence to treatment across illnesses, we propose to test the
effectiveness of TM versus enhanced mHealth intervention (VPN Toolkit + TM) designed to help sustain and
improve long-term adherence (i.e., 24 months follow ups) to monitoring and antiviral treatment guidelines,
thereby reducing cancer health disparities among underserved at-risk Asian Americans with CHB leveraging
our existing cohort of CHB patients. The specific aims are: 1) Evaluate the comparative effectiveness of TM
vs VPN+TM for improving long-term adherence to monitoring (doctor visit and blood tests) every six months (6-
, 12-, 18-, and 24-month follow-ups) and ultrasound (at 12 and 24 months); 2) Compare the effectiveness of
TM vs VPN+TM in improving and sustaining medication adherence (measured through self-report and
electronic monitoring) among Asian Americans with CHB who meet antiviral treatment guidelines; 3) Examine
mediators of intervention effectiveness, including dose-response (i.e., utilization of the TM and VPN toolkit),
information (knowledge), motivation, and self-efficacy. Our comparative study of mHealth approaches will
demonstrate how technology-based interventions can be integrated most effectively into real-world clinical
settings to reduce HBV-related liver cancer disparities. If effective, this VPN+TM intervention is a highly
disseminable intervention with the potential to have a significant impact on reducing viral-related cancer
disparities among underserved Asian Americans and other highest-risk populations.

Public health relevance
PROJECT NARRATIVE Full Research Project 1 – Liver Cancer Long-Term Adherence to Monitoring/Treatment in Underserved Asian Americans with Chronic HBV Asian Americans account for over 50% of Americans with chronic hepatitis B (CHB) and the highest incidence and mortality rates of hepatocellular carcinoma (HCC) among any racial/ethnic groups in the U.S. The proposed study leverages our existing cohort of CHB patients to test the effectiveness of text messaging (TM) versus enhanced mHealth intervention (Virtual Patient Navigation Toolkit + TM) designed to help sustain and improve long-term adherence (i.e., 24 months follow ups) to monitoring and antiviral treatment guidelines thereby reducing cancer health disparities among underserved Asian Americans with CHB. Our comparative study of mHealth approaches will demonstrate how technology-based interventions can be integrated most effectively and efficiently into real-world clinical settings to reduce HBV-related liver cancer disparities.